MULTIPLE DOSE ORAL, SAFETY, TOLERANCE RO23-7429 (TAT) HIV--ACTG 213

Compare efficacy and tolerance of multiple doses of potential anti-HIV drug and AZT or DDI in HIV-infected persons with 50 to 500 CD4 cells.